Tick Resources Core

TICK RESOURCES CORE
Abstract: The overarching goal of the Tick Resources Core within this P01 application is to provide support to
all three research projects and share reagents, materials, and new technologies with the scientific community.
Requests from the community will be handled through the Biodefense and Emerging Infections Research
Resources Repository (BEI) website (www.beiresources.org). BEI was established by the National Institute of
Allergy and Infectious Diseases and has been managed under contract by the American Type Culture Collection
for fifteen years. The Core Leader Dr. Jonathan Oliver at the University of Minnesota will continue to collaborate
with co-Investigator, Dr. Ulrike Munderloh. Their laboratories have made substantial contributions to developing
and refining techniques for mutagenesis, plasmid-based complementation, and functional genomics for
rickettsial agents in addition to developing a membrane feeder system for ticks. They have contributed 22 out
of 30 Rickettsiales species for sequencing in the “Rickettsiales Genomes” project and has an outstanding record
of distributing tick cell lines and microbial isolates to the scientific community.
Aim 1 of the Tick Resources Core will provide and develop tick-vector-based tools to support the research for
all three research projects within this P01 application. Aim 2 of the Tick Resources Core will characterize the
transcriptomic response of established experimental tick cell lines to infection by tick-borne pathogens and
develop novel cell lines suitable for analyses of immune pathways that are activated or repressed in response
to pathogens. These aims will be achieved through RNA interference by oral exposure in ticks and the
development of Clustered Regularly Interspaced Short Palindromic Repeats (CRISPR/Cas9) tick cell lines.
Model organisms such as Drosophila melanogaster have a myriad of tools that facilitate the study of pathogen-
arthropod interactions. They also provide critical insights to the fields of entomology, microbiology, and
immunology. However, we present strong evidence in this P01 application that Ixodes scapularis ticks have
evolved entirely different principles that govern microbial infection, dissemination, and immunity. Therefore, a
strong Tick Resources Core is of utmost importance to support all three Projects within this P01 application. By
providing existing I. scapularis-based tools and developing novel technologies for investigators, the Tick
Resources Core will contribute to uncovering novel paradigms in I. scapularis-microbial interactions. This
scientific knowledge has potential implications for basic and translational science.